Inflammation in MERTK-dependent retinitis pigmentosa

PROJECT SUMMARY/ABSTRACT
The biological process heretofore implicated in MERTK loss-of-function-associated Retinitis Pigmentosa (RP) is
defective phagocytosis of shed photoreceptor outer segments (POS) by retinal pigment epithelium (RPE) leading
to photoreceptor (PR) degeneration. Here we propose a shift in this paradigm. We have demonstrated that the
precise genetic ablation of Mertk in mice (Mertk -/- V2) results in deficient phagocytosis, but not PR degeneration.
Furthermore, PR degeneration in the original Mertk knockout (Mertk -/- V1 that is hypomorphic from Tyro3) or Mertk
-/- V2 Tyro3 -/- V2 mice is associated with RPE inflammation. Therefore, we hypothesize that loss of MERTK anti-
inflammatory signaling in the RPE is a critical event leading to RP. To test this hypothesis, we propose to (i)
conditionally ablate Mertk in Tyro3 -/- RPE to test if this recapitulates RPE inflammation seen in germline Mertk -
/- V1 and Mertk -/- V2 Tyro3 -/- V2 mice. An alternate possibility, RPE inflammation when Mertk is conditionally ablated
in Tyro3 -/- RPE notwithstanding, is that inflammation is a secondary consequence of loss of MERTK-mediated
phagocytosis and the consequent build-up of POS debris. We do not see POS build up even at 6 months in
Mertk -/- V2 or Mertk -/- V3 mice. We also detect RPE inflammation before eye opening (at p10) and thus inflammation
in the absence of MERTK is likely primary. To directly test this, (ii) we have generated a unique set of mouse
models wherein either the phagocytosis or anti-inflammatory signaling function of MERTK has been exclusively
mutated, leaving the remaining function intact. These mouse models will allow us to definitively test the outcome
of loss of MERTK-mediated phagocytosis alone in PR degeneration, as well as uncouple the effects of loss of
MERTK anti-inflammatory signaling alone from that of loss of MERTK-mediated phagocytosis. Complementing
these studies, we will test the orthologous mutations in differentiated human primary RPE in terms of their effect
on inducing RPE inflammation in presence or absence of POS. If inflammation underlies the etiology of MERTK
loss-of-function-associated RP, can it be therapeutically targeted to protect against vision loss? (iii) We have
obtained promising preliminary data that the FDA-approved JAK1/2 inhibitor ruxolitinib reduces inflammatory
gene expression in the Mertk -/- V1 RPE and the severity of PR degeneration in Mertk -/- V1 mice. Building on this
proof-of-concept, we will optimize the ruxolitinib regimen (dose and duration of treatment) through dose-
escalation studies to determine maximum protection against PR degeneration and vision loss. Taken together,
these three independent, orthogonal approaches are expected to reveal mechanistic insight supporting a novel
role of inflammation within the RPE itself as causally relevant to MERTK loss-of-function-associated RP, as well
as, provide a therapeutic avenue using small molecule JAK1/2 inhibitors (“Jakinibs”) already in clinical use for
this severe, early-onset form of RP.

Public health relevance
PROJECT NARRATIVE It is postulated that in MERTK mutation-associated Retinitis Pigmentosa, photoreceptors degenerate due to loss of MERTK-dependent phagocytosis in the retinal pigment epithelium (RPE). Here we posit that the crucial MERTK function is to dampen inflammation within the RPE itself, either in addition to or unrelated to its role in phagocytosis. We will compare the effect of conditional ablation of Mertk in the RPE with that of germline loss of Mertk on retinal inflammation, dissect the two functional roles of MERTK by testing mice with point mutations in Mertk that disable either the phagocytic or the anti-inflammatory function of this receptor, and investigate the effects of inhibiting JAK-STAT inflammation signaling pathway in preventing RPE inflammation and retinal dysfunction.